Seattle Summer Research Program in Geriatrics and Disparities

We are applying to renew the “Seattle Summer Research Program in Geriatrics and
Disparities” at the VA Puget Sound Health Care System (VAPSHCS), Seattle, WA. The VAPSHCS
ranks 4th in research funding among VAs and is home to one of the largest Geriatric Research,
Education and Clinical Centers (GRECC) in the VA system. Our program focuses on translational
research in age-related diseases including cancer and cachexia, sarcopenia and frailty, and
cognition in neurodegenerative diseases. Through the GRECC’s continued mission to bridge
geriatric research, education, and clinical care, we successfully leveraged the pilot VA ORD
Summer Research Program to establish the only VA-centered summer research program at the
VAPSHCS. We successfully met or exceeded participant enrollment goals and our self-guided
approach for training modules was well-received. Program alumni completed health science
baccalaureate degrees, entered clinical internships, co-authored peer-reviewed manuscripts, and
presented research findings at regional conferences. The purpose of this program is to ensure the
VA remains a global leader in scientific discovery by enhancing the scientific workforce through
providing mentored research experiences and related educational opportunities to the next
generation of healthcare professionals from diverse backgrounds. We have assembled successful,
dedicated faculty, with extensive mentoring histories to trainees from nationally underrepresented
groups at all academic levels, to effectively carry out the program objectives with a central focus on
reducing disparities in the VA scientific workforce, health science research, and healthcare
delivery. With this renewal proposal, we remain enthusiastically committed to promoting
retention of well-trained healthcare professionals from diverse backgrounds who will be
competitive for research and career opportunities in mission areas important to the VA. This will
lead to engagement with broader perspectives and encourage innovation and excellence in
research and patient care.

Public health relevance
The number of geriatricians is declining yet the geriatric population is rising. This is an issue for Veterans who are older and develop more age-related diseases than non-Veterans. Aged persons are also under- represented in aging research. The pilot VA Summer Research Program exceeded enrollment goals and alumni achieved numerous academic accomplishments. With this renewal, the Seattle Summer Research Program will continue enhancing the VA scientific workforce by providing research experiences and educational opportunities to the next generation of young investigators. This program aims to endorse the pursuit of research careers in geriatrics and gerontology within the VA by providing training in research conduct and exposure to the VA research enterprise. This program will also promote strategies for maintaining productive research careers in geriatrics and gerontology within the VA by mentoring in professional development and promoting awareness for disparities in biomedical research and health care delivery.